Promoting child respiratory health through novel psychosocial targets: An investigation of a maternal mental health intervention

ABSTRACT
Respiratory problems during childhood, including reduced lung function and asthma symptoms, present a
threat to healthy child development. There is increasing evidence linking prenatal and early childhood
adversity, such as poverty, violence, or maternal depression, to multiple respiratory health problems over the
lifecourse. Childhood adversity may be a promising target for prevention of respiratory problems, but has never
been the focus of a randomized control trial. In addition, there is a dearth of longitudinal evidence on how
childhood adversity impacts respiratory health from low resource settings, such as low-and-middle income
countries (LMICs), where the majority of the disease burden lies. In this study, we propose leveraging an
ongoing birth cohort with a randomized controlled trial of a maternal depression intervention to generate
important evidence on how childhood adversity impacts child respiratory health. Specifically, we will test
whether a maternal depression intervention is an avenue for improving child respiratory function. In addition,
we will study how multiple adverse experiences from pregnancy through middle childhood affect respiratory
health in early adolescence in a low resource setting. We will achieve this by expanding on the Bachpan study,
a birth cohort of roughly 825 mother-child dyads in rural Pakistan (R01HD075875, PI: Maselko). Led by a
strong and multi-disciplinary team, the Bachpan study is a birth cohort with a nested cluster randomized
controlled trial (cRCT) of a maternal depression intervention. Building on our team’s successful track record in
implementing the Bachpan cohort study from pregnancy through child age 8, this proposal will fund an
additional data collection wave focused on lung function and respiratory symptoms at child age 11. The
resulting unique dataset enables us to test several key hypotheses about the impact of common adversities
(poverty, violence, and maternal depression) spanning multiple development periods (pregnancy, infancy, early
childhood, middle childhood) on respiratory health at age 11, as well as the potential role of a psychosocial
maternal depression intervention. Additionally, hair-derived markers of child hypothalamic-pituitary-adrenal
(HPA) axis activity are available for a subset of the children from multiple time points, facilitating an analysis of
potential physiological pathways through which adversities may shape respiratory health. This innovative and
cost-effective study will allow us to capitalize on an existing study infrastructure, cRCT design, and extensive
longitudinal dataset to: (1) test whether targeting maternal mental health may have benefits for child respiratory
health, and (2) gain a holistic understanding of how childhood adversity and physiological regulation during
varying developmental windows (prenatal, infancy, early childhood, middle childhood) relate to child respiratory
function at age 11.

Public health relevance
Narrative The goal of this study is to elucidate the relationship between childhood adversities and child respiratory function. The findings from this study will improve our understanding of risk and resilience factors in child respiratory health that may serve as targets for future intervention efforts.